Defining TRPV4 contribution of Schwann cells to oral cancer pain

PROJECT SUMMARY
The K23 Career Development Award will strategically prepare the recipient to become a proficient scientist with
a specialization in patient-oriented translational research study design and implementation, as well as an in-
depth understanding of the neurobiology of oral cancer pain mechanisms. Additionally, the award will equip the
recipient with the necessary professional skills to establish an independent career in patient-oriented orofacial
pain research. BACKGROUND. Patients with oral cancer experience intense and incapacitating pain caused by
mechanical pressure or stretching at the cancer site. The existing approaches for pain management, which
involve opioid analgesics, have been inadequate. While the exact mechanisms that trigger pressure and stretch
hypersensitivity in oral cancer patients are not yet fully understood, initial research indicates that patients express
a functional pressure and stretch sensitive ion channel known as transient receptor potential vanilloid subtype 4
(TRPV4) in Schwann cells (SCs) that surround the axons of primary sensory neurons. In mouse models of oral
cancer pain, TRPV4 inhibition in the oral cancer has been shown to reduce mechanical nociception in the
orofacial region. SPECIFIC AIMS. This proposal aims to improve our understanding of oral cancer pain
mechanisms by (1) developing and validating assays of pressure and stretch sensitivity, which will provide new
methods to measure previously unexplored dimensions of oral cancer pain in patients; use genetically
engineered mice to test the impact of (2) TRPV4 deletion in SCs on orofacial functional pain and (3) trigeminal
neuronal hyperexcitability induced by pressure and stretch on the cancer. TRAINING. The candidate will be able
to attain immediate objectives by leveraging a resource-rich institutional environment and a cohesive training
plan that focuses on (1) clinical research protocol development and research methodology through a combination
of didactic training and hands-on experience in patient-oriented translational pain research, and (2) utilization of
genetically engineered mice to investigate the underlying mechanisms of oral cancer pain induced by pressure
and stretch. MENTORSHIP. The candidate will receive support from two experienced mentors, Dr. Brian Schmidt
and Dr. Donna Albertson. They have a long-standing expertise in oral cancer pain, cancer biology, and
neurobiology. IMPACT. Improved understanding of the peripheral TRPV4 role in oral cancer pain offers
significant potential for developing TRPV4 antagonists as novel analgesics for alleviating pain in oral cancer
patients. The successful fulfillment of the proposed training program will equip the candidate with the essential
abilities and expertise to lead an integrated research program on orofacial pain in an academic setting that
involves both patient-oriented and laboratory research.

Public health relevance
PROJECT NARRATIVE Patients with oral cancer experience severe and debilitating pain, yet the underlying mechanisms that lead to oral cancer pain are still elusive. The proposed studies will investigate oral cancer pain evoked by pressure and stretch in patients and their underlying mechanisms in pre-clinical models. A better understanding of oral cancer pain phenotypes may facilitate the development of more effective analgesics for treating cancer pain in patients.